TIM recognition of phosphatidylserine regulates innate and adaptive immunity

PROJECT SUMMARY (See instructions): The goal of Project 2 is to understand how TIM proteins regulate immune responses and autoimmunity via their recognition of phosphatidylserine on apoptotic cells. We discovered the Tim (T cell- Imunoglobulin-Mucin) genes, which we showed regulate tolerance, Th2 cytokine production, and asthma. We propose to: Specific Aim 1. Determine the functional consequences of TIM-4 and TIM-3 on APC binding to phosphatidylserine on apoptotic cells. We will examine effects on (a) anti-inflammatory cytokine production: IL-10, TGF-|3; (b) expression of coinhibitory molecules: PD-L1, PD-L2, B7-H3, B7-H4; (c) expression of co-stimulatory molecules: B7-1, B7-2, ICOS-L, CD40; (d) PGE2 and IDO production. Specific Aim 2. Determine the functional consequences of TIM-4 and TIM-3 on APC binding to phosphatidylserine in a pro-inflammatory context and determine the effects of TIM-1 and TIM-3 on T cells binding to PtdSer on an apoptotic APC. We will examine the (a) effects of TIM-4 or TIM-3 mediated phagocytosis of apoptotic versus necrotic cells on APC function in pro-inflammatory conditions; (b) determine the effects on T cell activation and TReg development of TIM-1 and TIM-3 on T cells binding to PtdSer on an apoptotic APC; and (c) determine how the health of the APC regulates T cell responses through TIM-1 and TIM-3. Specific Aim 3. Determine the structure/function relationship of TIM alleles on recognition of phosphatidylserine, phagocytosis, and T cell activation. We will perform a mutational analysis of the TIM-4 phosphatidylserine binding site and functional consequences of these mutations on phagocytosis; determine if HBA and BALB/c alleles of TIM-1 and TIM-3 have different capacities to recognize PtdSer and phagocytose apoptotic cells; and (c) determine how TIM-1 costimulation affects T cell activation in vitro and compare responses of TIM-1-expressing T cells from HBA and BALB/c mice. These studies together will greatly increase our understanding of the function of TIMs in the regulation of tolerance and Th2 responses, and will characterize a crucial regulator of CD4 T cell differentiation and a novel and extremely important asthma susceptibility gene family.

Public health relevance
RELEVANCE (See instructions): TIM proteins recognize dead cells and help remove them from the body. We will find out how the TIMs remove dead cells and how this regulates the immune response. This will allow us to understand the development of and design therapies for asthma, allergies, and autoimmune disease.